Integrated Public Health and Academic Collaboration for Infectious Diseases Control (iPHAC-IDC): Implementation of One Health approaches to pandemic preparedness and adolescent HIV prevention

PROJECT SUMMARY/ABSTRACT
Public health threats including emerging infectious diseases (EIDs) have highlighted the need for strengthening
surveillance and laboratory systems for faster and smarter outbreak response. The Thai Department of
Diseases Control (DDC), the Department of Medical Sciences (DMSc), Ministry of Public Health have
collaboratively worked with Chulalongkorn University (CU) and the Thai Red Cross Society (TRC) on HIV
research and other emerging endemic infectious disease surveillance, prevention, and control. This proposal
will launch the “Integrated Public Health and Academic Collaboration for Infectious Diseases Control (iPHAC-
IDC): Implementation of One Health approaches to pandemic preparedness and adolescent HIV prevention”,
a collaborative nested network among infectious disease control researchers from DDC, DMSc, CU and TRC,
as well as EID experts in the USA and France. The iPHAC-IDC will establish an integrated and sustainable
network to prepare for future disease outbreaks in Thailand. We will conduct research to 1) Develop and
implement the NextGen Public Health Surveillance Approaches by using the PCR, next-generation
sequencing, and multiplex serology assays to identify novel viruses, characterize the genomes of new-rare
viral strains of endemic diseases, EIDs, and AMR. These genomic data will be integrated with clinical and
epidemiologic data to create a pathogen genomic surveillance platform. In addition, genomic-mathematic
models will be developed and embedded in the platform for real-time analysis. One Health surveillance
approaches in the environment, including wastewater and air, and SARS-CoV-2 reverse zoonoses in wildlife
will be pursued. 2) Develop and implement the GLLP curriculum at the School of Global Health by creating a
GLLP curriculum at the Faculty of Medicine, Chulalongkorn University, in two pattern courses; A mandatory
course in the One Health Branch of the Medical Sciences program and an elective course for other graduate
students and a lifelong learning platform for all participants with an option to keep the credits for further claims
after enrollment to CU. 3) Develop a youth-focused HIV prevention service model in the government hospital
network by establishing youth-focused clinics that provide comprehensive HIV education and prevention with
pre-exposure prophylaxis leveraging social network strategies, and improving gonorrhea antimicrobial
genomics resistance surveillance.
This research will advance our understanding of the risk of EIDs and endemic diseases and strengthen in-
country public health research capacity and promote laboratory workforce development for pandemic
preparedness and adolescent HIV prevention.

Public health relevance
PROJECT NARRATIVE This proposed public health and academic research network (iPHAC-IDC) brings in-country partners in infectious diseases prevention and control in Thailand from the Department of Diseases Control, the Department of Medical Sciences, the Thai Red Cross Society, Chulalongkorn University, and world-class international partners to build a pandemic preparedness system by developing faster and wiser outbreak response using molecular, serologic, and data integration tools. In addition, this team will develop and implement a post- graduate GLLP curriculum at Chulalongkorn University for sustainable and long-term public health workforce development. The network will conduct HIV and STI prevention and detection research to reduce new HIV cases in Thailand by developing adolescent HIV prevention with pre-exposure prophylaxis using social network strategies and enhancing the gonorrhea antimicrobial resistance surveillance system.